Establishing the PhenX Toolkit as a Biomedical Knowledgebase

PROJECT SUMMARY/ABSTRACT
The goal of PhenX (consensus measures for Phenotypes and eXposures) is to provide investigators
with standard measurement protocols (e.g., questionnaires, bioassays, physical measurements) to improve
the quality and consistency of data collection and increase the impact of individual studies. Over time, this
common currency will enable investigators to more easily combine studies to increase statistical power and
compare studies to validate findings. Enabling analysis of shared data should lead to a better
understanding of the etiology, progression, and treatment of human disease, ultimately leading to
improvements in patient care, health outcomes, and quality of life. To this end, PhenX has established a
freely available, web-based catalog of measurement protocols intended for use in genomic, clinical,
translational, and epidemiological research with human participants. The PhenX Toolkit content and
features are driven by the scientific community. The PhenX Steering Committee (SC) provides overarching
guidance and each measurement protocol in the PhenX Toolkit is selected by a Working Group (WG) of
experts using a consensus-based process that relies on input from the scientific community.
The research plan will establish the PhenX Toolkit as a sustainable knowledgebase that organizes,
accumulates, and annotates standard protocols and links them to relevant resources and data. Specifically,
this administrative supplement will expand the Toolkit to address medical cannabis use, polysubstance use,
and recovery. The specific aims of this administrative supplement are to (1) review and adjust stigmatizing
language in the Substance Abuse and Additions (SAA) collections, (2) identify pertinent linkages among
SAA measurement protocols and other protocols in the PhenX Toolkit, (3) address gaps in SAA coverage
related to Medical Cannabis Use, Polysubstance Use, and Recovery, and (4) disseminate results to the
scientific community. This effort will support NIDA-funded initiatives, raise awareness of the Toolkit as a
valuable resource, and attract additional users to the Toolkit. Widespread adoption of PhenX measures will
facilitate cross-study analysis, thus increasing the scientific impact of individual studies.

Public health relevance
PROJECT NARRATIVE The research plan will establish the PhenX Toolkit as a sustainable knowledgebase that organizes, accumulates, and annotates standard protocols and links them to relevant resources and data. Specifically, this administrative supplement will expand the Toolkit to address Medical Cannabis Use, Polysubstance Use, and Recovery and will support initiatives, raise awareness of the Toolkit as a valuable resource, and attract additional users to the Toolkit. Widespread adoption of PhenX measures will facilitate cross-study analysis and thus increase the scientific impact of individual studies.